Targeting Inflammation-Induced Changes in Brain Reward Signaling and Motivational Deficits in Patients with Schizophrenia Using an Anti-Inflammatory Challenge

Project Summary
The CNS mechanisms underlying motivational deficits in patients with schizophrenia are poorly understood.
These deficits significantly contribute to negative symptoms, which are strongly related to poor functional
outcomes and nonresponse to antipsychotic therapies. Data from our group and others have shown that
increased peripheral inflammatory markers, such as tumor necrosis factor (TNF), are associated with
motivational deficits and negative symptoms in patients with schizophrenia. Regarding the mechanisms
involved, our data indicate that in patients with schizophrenia, TNF is associated with decreased activation in
ventral striatum in response to reward anticipation as well as increased activation in anterior insula in response
to increasing perceived effort. These data are consistent with previous results from individuals administered
inflammatory stimuli and from patients with depression that indicate that inflammation targets ventral striatum
and anterior insula to lead to downstream changes in reward processing and motivation-related behaviors.
Taken together, these findings support the hypothesis that inflammation plays a role in motivational deficits and
negative symptoms in patients with schizophrenia through effects on the ventral striatum and anterior insula.
Nevertheless, the cause and effect nature of this relationship remains unclear. Work from our group and others
suggest that reducing inflammation with the TNF antagonist infliximab improves motivated-related behaviors in
patients with depression and high inflammation, and our preliminary data indicate that infliximab improves
effort-based motivation in depression through effects on ventral striatum. However, previous studies of anti-
inflammatories, including cytokine antagonists, in patients with schizophrenia have been limited by a lack of
specificity for patients with increased inflammation and a lack of focus on inflammation-related behavioral
changes (e.g. amotivation). Herein, we propose a mechanistic clinical trial in which patients with schizophrenia
with high inflammation and motivational deficits will be randomized to an anti-inflammatory challenge with
infliximab or placebo. We will then test the hypothesis that infliximab (vs placebo) will increase ventral striatal
activation in response to reward anticipation and decrease activation of the anterior insula in response to
increasing effort using fMRI. In addition, we will assess the response of objective and clinical measures of
motivation. Thus, the goals of the proposed research are to use a biomarker-driven approach to determine
whether inhibition of TNF with infliximab (compared to placebo) increases activation of the ventral striatum and
decreases activation of the anterior insula during an effort-based reward task (Aim 1), while improving
objective and clinical measures of motivation (Aim 2) and exploring infliximab’s effects on other brain regions
and behaviors to address specificity (Aim 3). In sum, this study will reveal CNS mechanisms of amotivation in
schizophrenia and provide biomarkers and targets that will focus future research and support development of
precision therapies for amotivation and ultimately negative symptoms in relevant schizophrenia subgroups.

Public health relevance
Project Narrative Increased inflammation in patients with schizophrenia is associated with motivational deficits and negative symptom severity, which in turn contributes to poor functional outcomes including excess morbidity and mortality as well as treatment nonresponse. Increased inflammation is associated with alterations in activation of the ventral striatum and the anterior insula, brain regions that subserve reward, effort, and motivation. This project will provide mechanistic insight into whether inflammation impacts these brain regions to contribute to motivational deficits in a subgroup of patients with schizophrenia and will provide a foundation for personalized treatments that reduce inflammation to ultimately reverse the devastating impact of amotivation and negative symptoms in patients with schizophrenia and increased inflammation.